Fusion pore structure and dynamics

Project Summary/Abstract
Membrane fusion is a fundamental process in eukaryotic cells, yet the precise molecular mechanism(s) by
which proteins catalyze the merger of lipid bilayers has yet to be elucidated. We address the nanomechanics
of membrane fusion reactions by focusing on the fusion of synaptic vesicles (SV) with the presynaptic plasma
membrane in neurons. This fusion event results in the release of neurotransmitters and thus underlies
neuronal function. In synapses, interactions between v- and t-SNAREs initiate the first step in the fusion
reaction: the formation of the fusion pore. These are short-lived, channel-like structures that represent the first
aqueous connection between the lumen of secretory vesicles and the extracellular space. To understand the
biophysics of the fusion reaction, it is imperative to address the dynamics of SNARE complexes and the fusion
pores that they form. In project 1, we leverage a novel system, innovated via our current R35 (that ends soon),
that enabled the first µsec measurements of single, recombinant, reconstituted fusion pores. In this system, a
fusion pore forms between a v-SNARE-bearing nanodisc (ND) and a black lipid membrane (BLM) that harbors
t-SNAREs (ND-BLM system). The rigid membrane scaffold around the ND limits pore dilation and thus holds
pores in a nascent state. Importantly, pores are interrogated electrophysiologically, and the high sampling rate
revealed dynamics that had not been previously observed. This system enables us to quantitatively measure
opening and closing rates, and to estimate pore size via unitary pore currents. We will continue this line of
study, to: address the regulation of fusion pores by accessory proteins, relate structural transitions in SNAREs
with kinetic transitions in fusion pores, create progressively larger NDs to quantitatively study the pore dilation
step, determine the molecular basis for the cation selectivity of pores, and address the activation energy for
pore opening. In project 2, we will determine the structure of fusion pores formed between v- and t-SNARE-
bearing NDs, via cryo-EM. For this work, we utilize DNA nanostructures to obtain the required sample
homogeneity needed for single-particle averaging. These DNA nanostructures will also be used to dictate the
organization of SNARE proteins, so that we can infer the structure of the fusion pore via functional assays.
Finally, in project 3, we extend our studies of fusion pores to study the modes of SV release in neurons. We
will develop robust, rigorous, optical approaches to “size” the SV fusion pore using dyes with different radii.
This work will directly address the controversy of whether SVs always undergo full fusion collapse (FFC), or if
they sometimes undergo kiss-and-run (K&R) exocytosis in which the fusion pore closes prior to dilation and
merger. K&R exocytosis, through a non-dilating fusion pore, would hinder glutamate efflux; this would have a
major impact on the post synaptic response to dramatically impact information flow in the nervous system. In
summary, our goals are to understand the dynamics, and determine the structure, of the SV fusion pore, and
directly address the FFC versus K&R controversy.

Public health relevance
Project Narrative Membrane fusion is a crucial cellular function that mediates key processes including fertilization, viral entry into host cells, and communication between cells. By focusing on the membrane fusion step that mediates the release of neurotransmitters, we will gain insights into synaptic transmission, and membrane fusion reactions in general. These insights will provide novel targets for intervention in mental disorders where exocytosis and neuronal communication are impaired.